Molecular Regulatory Mechanism of a Cartilage-Enriched GPCR in Joint Maintenance

PROJECT SUMMARY/ABSTRACT
Osteoarthritis (OA) is a leading cause of disability worldwide with no disease-modifying therapies available.
One of the hallmarks of OA is cartilage degeneration with abnormal chondrocyte differentiation. It is known
that chondrocytes can respond to various signaling via the G protein-coupled receptors (GPCRs), which
represent the largest class of targets for drug development. However, due to the lack of relevant animal
models, we have a limited understanding of how GPCR-mediated signaling pathways regulate chondrocyte
homeostasis and OA pathogenesis. In this project, we will investigate the molecular regulatory mechanisms
of a cartilage-enriched GPCR named ADGRG6 in maintaining cartilage and joint homeostasis. Our
preliminary studies show that ADGRG6 is highly expressed in healthy cartilage, but its expression is
gradually reduced under OA conditions in both human patients and trauma-induced OA mouse models. Loss
of Adgrg6 in cartilage lineages leads to OA-like joint structural changes associated with impaired Gs signaling
and reduced SOX9 expression. In contrast, overexpression of Adgrg6 in cell cultures leads to a
chondroprotective effect in vitro. Based on these findings, we hypothesize that ADGRG6 is required for
postnatal joint cartilage maintenance. We will test our hypothesis with three specific aims: in Aim 1, we will
investigate the chondrocyte-specific role of ADGRG6 with genetic deletion; in Aim 2, we will elucidate the
functional link between ADGRG6/Gs signaling and SOX9 with cell cultures and genetic mouse models; in
Aim 3 we will determine if ADGRG6 agonism can protect mice from OA development. Completion of this
project will reveal the molecular mechanism of a cartilage-enriched GPCR in regulating joint homeostasis.
These insights will support future strategies for targeting GPCRs for OA therapeutics.

Public health relevance
PROJECT NARRATIVE Osteoarthritis (OA) is the most common form of degenerative joint disease with no disease-modifying therapies available. In this proposal, we will generate a new mechanistic understanding of how cartilage-enriched G protein-coupled receptors (GPCRs) regulate cartilage homeostasis and OA progression using mouse models. Given the fact that GPCR represents the largest class of targets for drug development, this proposal will provide insights to support strategies for targeting GPCRs for OA therapeutics.